Flu Finders: Data Literacy through Wastewater Monitoring

To prepare for challenges in the biomedical field, students must be data-literate. American students’ underperformance
in STEM fields, and the limiting effect that has on the STEM workforce including roles in biomedical science, is an
ongoing concern (Sass, 2015; Rosenzweig et al., 2021). Problem-based learning, which emphasizes authentic
problem-solving, is one flexible instructional method that has been effective at building data literacy skills and improving
students’ science achievement, but is also time-consuming and challenging to implement (Friedrich et al., 2024; Merritt et
al., 2017). Building tools that help students develop the skills to navigate a data-centric world and see the value of science
in their lives, while enabling educators to respond to their students’ needs, would help address this critical issue.
This SBIR Phase I & II award will enable Killer Snails LLC to develop a multimodal learning experience, Flu Finders,
that uses a Problem-based learning framework to deliver Next Generation Science Standards-aligned content to students in
grades 7-10. Killer Snails will collaborate with virologist Dr. John Dennehy to create 5 class period-length challenges
about monitoring the spread of flu in a community by interpreting data from sources including wastewater and clinical
outcomes. Dr. Dennehy is an expert and innovator in the field of using RNA sequencing on samples of wastewater to
monitor viral diseases, an impactful, surprising, and data-driven field that forms the basis of the Flu Finders narrative.
Flu Finders will leverage the features of an interactive, personalized website to support a Problem-based learning
curriculum, allowing students to build data literacy, digital fluency, and problem-solving skills that are critical throughout
STEM subject areas. Flu Finders will also address the need for individualized feedback with a real-time educator
dashboard that summarizes student actions and highlights actionable steps to support building new skills. This approach
will address issues of scalability that make Problem-based learning less likely to be implemented in classrooms.
Flu Finders has three innovative features: (1) Interactive Data Visualization Builder to enable students to explore the
data collected in the virtual environment and power their inferences and decision-making (2) Collaborative Interface to
enable students to collaborate on a final presentation, using a proprietary design structured to support sharing their
recommendations and evidence-based reasoning. (3) Real-Time Educator Dashboard Optimized for Problem-Based
Learning to highlight progress and diagnostic recommendations for tailored, timely, contextual educator feedback. The
dashboard will display actionable learning analytics of individual student work and the collaborative interactions between
students. The dashboard will highlight evidence of data literacy skills, or the need for support from the educator.
Our innovative features will be iteratively tested to examine how they contribute to students' learning. Our evaluators,
Marcy Peak LLC, will conduct a randomized control trial investigating the extent to which Flu Finders influenced
students’ content knowledge, data literacy, digital fluency, and problem-solving skills, and subjective value of science, as
well as educators’ ability to monitor and support students during problem-based learning activities. Flu Finders’
integrated narrative, curriculum, and digital platform will meet the data-centric needs of science learners and educators.

Public health relevance
The National Science Teachers Association and new state standards demonstrate the need for building data literacy, digital fluency, and problem-solving skills in students to prepare for our increasingly data-centric world. This SBIR Phase I & II award will enable Killer Snails, LLC to develop Flu Finders, a digital learning platform where 7th-10th grade students take on the role of scientists monitoring the spread of influenza by collecting, analyzing, and interpreting data from sources like wastewater and clinical outcomes, and collaborating to provide evidence-based, meaningful advice to their community. Through interactive user-generated data visualization, collaborative presentations, and a real-time responsive educator dashboard, Flu Finders helps students gain biomedical content knowledge and foundational STEM skills while serving as a model for how technology can scale up effective but resource-intensive frameworks like Problem-based learning to benefit all STEM learners.